Predicting Suicidal Behavior in Veterans with Bipolar Disorder using Behavioral and Neuroimaging Based Impulsivity Phenotypes

Project Summary
Studies examining the relationship between psychiatric illness and suicide from the Department of Veterans
Affairs indicate that individuals with bipolar disorder have the highest rate of suicide, which is even greater
compared to post-traumatic stress disorder, schizophrenia and major depression. When left untreated, bipolar
disorder has a 5-15% risk of death by suicide, making it a top priority for Veterans' mental health care.
Individuals with bipolar disorder behave impulsively – even during euthymic periods and understanding the
relationship between impulsivity and suicidal behavior in bipolar disorder may assist in the identification of
individuals at greatest risk for a future suicide attempt. Progress in understanding this relationship has been
significantly hampered, however, by the conflation of different measures of impulsivity. Impulsivity can be
measured as a relatively stable trait using self-report measures or as a state measure assessed through the
use of behavioral paradigms sensitive to changing environmental contingencies. Models of state impulsivity
have focused on (1) “rapid-response inhibition” involving difficulty inhibiting responses that are prepotent in the
context of changing environmental situations and (2) “choice impulsivity” defined as the inability to delay
gratification for a larger reward. These models correlate weakly, but strongly overlap with brain regions
implicated in the neurobiology of bipolar disorder. We propose investigating measures of state and trait
impulsivity in 40 euthymic Veterans with bipolar disorder (BD) and a suicide attempt history (BD+S), 40
euthymic Veterans with bipolar disorder and no suicide attempt history (BD-S) and 40 healthy controls (HC).
The primary suicide outcome measure in this study will be suicide attempts assessed using the Columbia
Suicide Severity Rating Scale and medical record review. This will be complemented through the use of a
broader composite suicide outcome measure based on the occurrence of any of 5 types of suicidal behavior
including: (1) death by suicide; (2) suicide attempt; (3) interrupted suicide attempt; (4) aborted suicide attempt;
or (5) preparatory suicidal acts. Following comprehensive baseline clinical, neuropsychological and
neuroimaging assessments all Veterans will subsequently complete 6- and 12-month in-person follow-up
clinical assessments of mood and suicidal behavior. Novel measures of trait impulsivity in this study will include
urgency and impulsive/premeditated aggression. We will assess the relationship between impulsive aggression
and social cognition, functional disability and neurocognitive functioning in BD+S. We will further investigate
two neural circuits tapping state measures of rapid response inhibition (using a go/no-go task) and choice
impulsivity (using a delay discounting task), respectively, using functional magnetic resonance imaging and
neurite orientation dispersion and density imaging, which will provide novel measures of fiber arrangement and
neurite density in tracts connecting gray matter regions. Dynamic causal modeling will be used to empirically
test causal models regarding the interaction of brain regions comprising these two circuits respectively.
Machine learning will be used to integrate baseline trait and state measures of impulsivity to longitudinally
predict suicidal behavior over one year. The specific aims of this study are: (1) to investigate the relationship
between trait measures of impulsivity and suicide attempt history in Veterans with bipolar disorder; (2) to
investigate the neural circuitry underlying two models of state impulsivity and their relationship to suicide
attempt history in Veterans with bipolar disorder; and (3) to identify which combination of impulsivity measures
differentiates BD+S from BD-S and HC at a baseline timepoint and can be used to predict suicidal behavior
longitudinally over 1 year.

Public health relevance
Studies examining the relationship between psychiatric illness and suicide from the Department of Veterans Affairs indicate that individuals with bipolar disorder have the highest rate of suicide, which is even greater compared to post-traumatic stress disorder, schizophrenia and major depression. When left untreated, bipolar disorder has a 5-15% risk of death by suicide making it a top priority in Veterans' mental health care. Individuals with bipolar disorder behave impulsively – even during euthymic periods and understanding the relationship between impulsivity and suicidal behavior in bipolar disorder may assist in the identification of individuals at greatest risk for a future suicide attempt. We propose assessing both trait and state measures of impulsivity using self-report measures and functional magnetic resonance imaging to predict the occurrence of suicidal behavior longitudinally over 1 year in Veterans with bipolar disorder.